Preparation for lung transplant discussions and decisions among people with cystic fibrosis

Project Summary
Cystic fibrosis (CF) is a progressive, fatal genetic condition (median age at death was 34 years in 2020). Lung
transplant (LTx) is a treatment for end-stage CF and confers 10 years median survival for adults with CF. In the
U.S., among CF patients with forced expiratory volume in 1 second (FEV1) less than 30% of predicted, more
patients die each year than undergo LTx. More than half of CF patients who die without LTx are never referred
for consideration. CF patients with lower socioeconomic status (SES) or non-White race have decreased
referral for LTx and worsened survival. Hispanic CF patients have a nearly 3-fold increased risk of death
without LTx compared to non-Hispanics. Patient preference may account for 25-40% of decisions to defer
referral, but choices may at times be informed by inaccurate assumptions regarding LTx. CF patients with low
FEV1 have high rates of anxiety and depression, which may contribute to avoidance of LTx conversations.
Increasing LTx comprehension, and promoting the process of deliberation, could reduce the number of people
with CF who die without LTx.
We collaborated with CF patients, caregivers, and physicians to develop Take on Transplant (ToT): a web-
based, patient-facing resource for LTx education. ToT shares personal narratives of CF patients and
caregivers and up-to-date, CF-specific, guideline-based medical information about LTx. The overall research
objectives are to test the efficacy of ToT compared to an attention control in a multicenter randomized clinical
trial incorporating mixed methods to assess preparedness for LTx discussions among CF patients with FEV1
<50% predicted (oversampling from communities of concern – low SES, Hispanic ethnicity, or non-White race),
explore the impact of ToT on patients’ psychosocial functioning, and assess patients’ and physicians’
perceptions and use of LTx education. Our research will examine patient-physician interactions and explore
factors that may determine if/when physicians discuss LTx with CF patients in communities of concern (e.g.
perceived eligibility for LTx, implicit bias, assessment of psychosocial factors) and the impact of ToT on
patients’ readiness for LTx discussions.
In line with National Institute of Nursing Research (NINR) priorities, our research focuses on improving a
process that disadvantages patients with lower SES, non-White race, or Hispanic ethnicity and leads to health
disparities. We aim to empower patients to discuss LTx. The proposed R01 will test the impact of ToT on
preparedness for LTx discussions, will oversample patients from communities of concern, and will evaluate
patient-physician dynamics, including implicit bias and discrimination, which may limit access to LTx in this
disadvantaged population.

Public health relevance
Project Narrative Our work aims to promote equitable access to lung transplant in a vulnerable population using up-to-date, cystic fibrosis-specific lung transplant education that supports self-efficacy and patient-empowerment in health care decisions. High-quality lung transplant discussions could improve clinical and psychological outcomes by changing attitudes, beliefs, and choices related to transplant. The Take on Transplant lung transplant decision support tool has the potential to expand the toolbox for engaging patients with cystic fibrosis in high-quality lung transplant discussions and aims to narrow the gap in access to transplant for individuals in disadvantaged groups, including those with lower socioeconomic status, non-White race, or Hispanic ethnicity.